Radon on the RADAR

ABSTRACT
Kentucky's high radon potential and high smoking rates create the perfect storm for the
overrepresentation of lung cancer cases. Our transdisciplinary, community-academic team-led project,
Radon on the RADAR (Residents Acting to Detect and Alleviate Radon) will address community concerns
about lung cancer by identifying geological and atmospheric conditions that increase radon intrusion into
homes, translating this knowledge into greater residential awareness of risk, enabling home radon testing
and report back, and growing access to affordable and adequate radon mitigation. We will team geologists
with citizen scientists to determine how new radon detection technology (i.e., Airthings) compares to
traditional charcoal kits and outdoor soil radon measurements over a range of atmospheric and geological
conditions to close a critical knowledge gap in our understanding of radon risk. The study will build
capacity in environmental health by: (a) training citizens in rigorous data collection and interpretation of
findings; (b) engaging these citizen scientists in creating and promoting library loan programs to increase
radon testing; and (c) creating sustainable environmental health action plans to alleviate radon exposure
in rural communities. Our overall hypothesis is that by increasing knowledge on how geological and
atmospheric conditions can impact radon, partnering with citizen scientists to use new radon detection
technology and translate the data, and by growing access to low-cost radon mitigation, we will reduce
radon risk. Aim 1 will use a citizen science approach to identify and train 60 community residents in four
KY counties to test for radon and evaluate change in environmental health literacy (EHL) and self-efficacy.
Aim 2 will compare indoor home radon values and soil radon values over time, controlling for atmospheric
conditions, seasonality, geology, topography, and smoking in the home. Aim 3 will create and evaluate a
pilot radon detector library loan program with 400 homeowners in the four counties. Aim 4 will launch the
radon detector loan program and examine changes in home testing and accessing geologically based
radon potential maps. Aim 5 will examine the impact of citizen scientist-led radon coalitions on reach,
effectiveness, adoption, implementation, maintenance, and environmental health literacy. The RADAR
study challenges and expands the current environmental health science paradigm by collaborating with
geologists and integrating their scientific approach. We will impact community concerns about high lung
cancer rates by: 1) transforming radon detection and report back using geoscience and new radon gas
detection technology; 2) developing a library-lending approach to increase radon testing; and 3) supporting
environmental action by creating and sustaining citizen science-led radon coalitions that share new
knowledge and engage health advocates, radon mitigation professionals, policymakers, builders, and
developers to promote improved radon management in rural Kentucky.

Public health relevance
PROJECT NARRATIVE The public is concerned about the high rates of lung cancer from environmental exposure to tobacco smoke and radon. We will identify geological and atmospheric conditions that increase radon intrusion into homes, translate this knowledge into increased residential awareness of lung cancer risk, facilitate home radon testing and report back, and increase access to affordable and adequate radon mitigation. By bringing residents and traditional (e.g., public libraries) and non-traditional (e.g., low interest loan providers) organizations to the table to reduce radon exposure, the way communities address environmental health issues will be transformed.